Fast multicolor confocal fluorescence imager for neural network mapping

Project Summary/Abstract
Brain functions are driven by highly dynamic neuronal activities operating within a complex neural
network. Impairment of neuronal connections during development causes neurodevelopmental disorders
such as attention-deficit/hyperactive disorder (ADHD) and autism spectrum disorder (ASD), which affect
learning ability and social skills. To identify the normal/abnormal connections of neurons and track individual
neurons at the sub-cellular levels and millisecond time scales for the investigation of the mechanisms of
neurodevelopmental disorder, multicolor barcode methods have been developed to label adjacent neurons
with different fluorophores. In addition, fluorescence imaging techniques that acquire multicolor spatial
information have emerged. However, there is no tool that enables simultaneous multicolor imaging at high
temporal resolution (>140 Hz) to capture the fast dynamics occurring between neurons and possible cellular
deformations or conformational changes in live, moving animals. Moreover, high spatial resolution and optical
sectioning capabilities are necessary since neurons are concentrated in an optically dense 3-D environment
and detailed sub-neuronal structures need to be resolved to observe neuronal connectivity.
During this R&D program, Physical Sciences Inc. (PSI), in collaboration with UMass Chan Medical
School (UMCMS), proposes to develop and demonstrate a high-speed (>140 Hz frame rate) multicolor
confocal fluorescence imager that can simultaneously capture multi-wavelength signals and display them
as separated or merged multicolor images and 3-D stacks. The proposed imager will be used to map complex
neuronal network activity and identify individual neurons in moving organisms. Technology innovations
include a novel spatiotemporally modulated (STM) imaging technology, which enables both confocal
scanning and simultaneous multi-wavelength excitations. The Phase I effort will focus on 1) developing a
fast multicolor confocal prototype imager employing four laser excitations; 2) validating the system with four
different fluorescent beads to demonstrate its capabilities of simultaneous multicolor imaging and optical
sectioning at high temporal resolution; 3) performing in vivo experiments with “NeuroPAL” (a Neuronal
Polychromatic Atlas of Landmarks) C. elegans wherein neurons express four (or more) different fluorescent
proteins that result in multicolor labeling based on stereotyped combination of neuron-specific reporters that
drive the expression of different colored fluorophores. These studies will demonstrate the technology
feasibility, and demonstrate its value to support a broad spectrum of neuroscience research efforts. This
R&D project will lay the foundation for the development and commercialization of a multicolor imaging
technology with high spatiotemporal resolution to study and understand of real-time neuronal dynamics in
live animals, offering a critical tool for neuroscience research.

Public health relevance
Project Narrative The goal of this project is to develop a multi-wavelength confocal imager capable of simultaneous detection of multiple fluorophores and labeled neurons at high speed (>140 frames per second). This technology is critically needed to study different types of neurons and their intricate connections that underpin both normal brain functions and neurological pathology. The proposed imager will provide neuroscientists with the capability of studying the detailed dynamics of neuronal activity and communication to understand the mechanisms of neurodevelopmental disorders.